EFFECT OF LOSARTAN VS ATENOLOL ON CAROTID WALL THICKNESS AND VASCULAR RESISTANCE

The goal of this study is to help define underlying pathophysiological mechanisms and the relationships between structural vascular change, insulin resistance, and hypertension.